Research and Career Training for Cellular, Biochemical and Molecular Scientists

Project Summary
As the current trend in medical schools is to reduce the amount of basic science being taught after
undergraduate training, it is more important than ever to maintain and expand basic science knowledge
through graduate-level scientific research training, especially in the fields of cellular, biochemical, and
molecular (CMB) sciences. Without constantly expanding our knowledge of how cells work at the most basic
level, it will become impossible to continuously develop novel treatments or cures. It is also now becoming
clear that one field can no longer work independently from others, and multi-disciplinary approaches are
needed to understand the ever-expanding complexity of biology. Our two-year training program, for second-
and third-year PhD students (4 per/year), brings together researchers from nine different departments/
programs at the Jacobs School of Medicine and Biomedical Sciences and School of Dental Medicine at the
University at Buffalo, with the primary goal of assembling a list of talented, interdisciplinary mentors, who use
a broad array of CMB techniques to answer wide-reaching experimental questions. Providing CMB-specific
training across many types of research areas will allow trainees to establish foundational research techniques
while still pursuing a topic of interest. As training in CMB sciences prepares students for a vast array of career
opportunities, but the scope of these opportunities is not always fully understood by students or mentors, we
also want to couple scientific training with career development training targeted specifically to CMB students
and their mentors. The second goal of this training program is to provide a career development class that will
aid trainees in discovering their interests, realizing their abilities, cataloging their skills, and creating their
brand. We will then show them how to translate this awareness into a personalized career choice. Finally, our
third goal is to integrate mentors into the career development process by teaching them how to prepare
trainees for diverse career opportunities and how to advocate for trainees at all stages of their careers. We
believe that providing Ph.D. candidates with earlier and more thorough career development training will help
them better understand the value of their degree and the array of opportunities available to them upon its
completion. We also believe that integrating mentors into the career development process will help them
provide discipline-specific training and produce trainees, both current and future, who are more confident of
their place and value in the biomedical workforce.

Public health relevance
Project Narrative Training in cellular, biochemical, and molecular (CMB) sciences prepares students for a vast array of career opportunities, though the scope of these opportunities is not always fully understood by students or mentors. Here, we aim to couple CMB-specific experimental training for students with CMB-specific career development training for both students and mentors, to produce trainees more confident of their place in the biomedical workforce and mentors who are better equipped to advise all future trainees.